Discovery and characterization of biocatalysts and metabolites for ribosomally encoded alpha-N-methylated peptide natural products

PROJECT SUMMARY / ABSTRACT
Since the discovery of penicillin in the 1920s, bioactive peptide natural products have been used as
antibiotic, antiviral, immunosuppressive, and anti-cancer agents. Many of these bioactive peptides harbor
backbone α-N-methylations and/or macrocyclizations, since these tailorings significantly improve peptide
pharmacokinetics. As seen in the blockbuster immunosuppressant cyclosporin A, α-N-methylated peptides have
increased structural rigidity, proteolytic resistance, and membrane permeability. Despite these advantages,
inefficient synthetic and in vitro processes hinder the production, screening, and optimization of α-N-methylated
peptides. In addition, natural sources of amide backbone-methylated peptides were thought to be completely
limited to inflexible nonribosomal peptide biosynthetic pathways. The goal of this work is to identify new α-N-
methylated metabolites and tease out the mechanistic and structural constraints of biocatalysts from our newly
discovered ribosomally encoded peptide natural product family named the borosins. Our first objective aims to
uncover rules of iterative catalysis, inhibition, and cooperativity in our model borosin system. Our second
objective targets the discovery and study of structurally complex borosin metabolites from cystic fibrosis
pathogens. Our last objective focuses on the mechanism and structure of α-N-methylation–dependent proteases
and macrocyclases. This research will create a diverse toolbox of flexible and efficient catalysts for the biological
production, screening, and optimization of genetically templated bioactive α-N-methylated peptides.

Public health relevance
PROJECT NARRATIVE The ability to produce and screen bioactive -N-methylated peptides is currently limited by inefficient synthetic methods and cumbersome non-ribosomal biosynthetic routes. The proposed research will enable the flexible production of genetically templated -N-methylated peptides that will streamline discovery and optimization of bioactive peptide therapeutics.